Rapid phenotypic detection of complex and emergent TB drug-resistance using a next-generation nanoluciferase reporter phage

Project Summary
Mycobacterium tuberculosis (M.tuberculosis) is the causative agent of tuberculosis (TB); although a treatable
disease TB remains a leading cause of morbidity and mortality globally. This in large is driven by the
unparalleled increase in anti- mycobacterial drug resistance. Approximately 10 million people fell ill with TB
in 2019, where 500 000 were new rifampicin resistant cases and 78% of rifampicin cases were multi-drug
resistant; compromising the most effective first-line drugs. In line with recent WHO guidance, the majority of
these patients are treated with all-oral short-course treatment incorporating bedaquiline and other novel
agents. Emerging drug resistance to these novel drugs is a critical threat to expansion of shortened, all-oral,
DR-TB treatment regimens. Current diagnostic assays do not incorporate resistance detection to these new
drugs, largely as a result of our incomplete understanding of the underlying genetic mechanisms mediating
resistance. As a result, a combination of genotypic and phenotypic techniques is required to monitor
resistance to these new drugs. Reporter mycobacteriophage assays represent a promising approach for
deriving phenotypic data in a replication-independent system, maintaining high sensitivity while reducing the
time to result attendant with growth-based methods. We created a TM4 phage vector that delivers a gene
cassette of the nanoluciferase (Nluc) reporter enzyme. The TM4-nluc phage was tested on a range of
auxotrophic and virulent clinical M. tuberculosis strains, assessing cellular limit of detection and compatibility
with drug susceptibility testing on a wide range of antimycobacterial drugs. We found that following a
preculture period, we could identify drug susceptibility consistent with WHO-endorsed treatment
concentrations to a suite of first-line and second-line drugs as well as novel and repurposed drugs
(bedaquiline, pretomanid, and linezolid). The overall objective of this research is to validate the
nanoluciferase phage for detection of resistance to novel anti-mycobaterial agents, will be accomplished in
two Aims. Aim 1 will establish the utility of the assay in paucibacillary conditions and mixed infection. Aim2
will derive correlations between established minimum inhibitory values around critical concentrations and
nanoluciferase fluorescence intensity measures, and validate these cut points in a established prospective
cohort study of MDR-TB treatment. An exploratory sub Aim will trial minimally processed sputum rather than
MTB culture for MTB detection and drug susceptibility testing. The proposed work will provide additional
validation on the TM4-nluc phage system and offer a quantitative phenotypic reference method and
complement to genotypic methods for diagnosis and antibiotic susceptibility testing.

Public health relevance
Narrative Mycobacterium tuberculosis, the causative agent of tuberculosis disease, remains a global public health challenge, and development of new interventions and identification of drug resistance are among the objectives of the World Health Organization End TB Strategy. Leveraging on the success of the TM4 mycobacteriophage and the sensitivity of the nanoluciferase reporter enzyme, the proposed work will offer a rapid, cost-effect phenotypic reference method drug susceptibility testing of M. tuberculosis.